ACTG 175--MONOTHERAPY VS COMBINATION THERAPY IN HIV PTS, CD4 200-500

ActG 175- a randomized, double blind phase II/III trial of monotherapy vs combination therapy with nucleoside analogues in HIV-infected persons with cd4 cells more than 200 and less than 500 mm3.